Biomedical Informatics and Data Science Training at Yale

PROJECT SUMMARY/ABSTRACT
The Yale Biomedical Informatics and Data Science Training Program—directed by Profs. Cynthia Brandt and
Mark Gerstein— with 33 core faculty from 12 departments and five schools, is based in the Yale Center for
Medical Informatics (YCMI) and the Computational Biology and Bioinformatics (CBB) Program at Yale. The
program and faculty reflect the diversity and depth of Yale’s collaborative Biomedical Informatics research
environment. We continue our training focus on the following informatics and data science areas: 1) health
care/clinical informatics, 2) translational bioinformatics, and 3) clinical research informatics.
This renewal features key enhancements to our training program including (1) an updated curriculum based on
the evaluation and feedback of trainees and faculty, with many new data science, computer science, and
informatics courses; (2) faculty leadership and integration with university science initiatives such as a new
Institute of Data Science with an associated Center for Biomedical Data Science (CBDS) and a new Master of
Science in Health Informatics, all of which have resulted in hiring many additional faculty and provided
opportunities for research collaborations. Predoctoral training is carried out primarily in Yale’s interdepartmental
PhD program in Computational Biology and Bioinformatics (CBB). This program was inaugurated in 2002 and
has graduated over 56 PhDs many of whom are now leaders in their respective fields. Postdoctoral fellows with
a doctoral degree in the health professions or in an area of science other than informatics will enroll in one of
three research-oriented graduate programs: CBB (study for an MS or PhD), the Clinical Informatics track in the
Master of Health Science (MHS) degree, and the MS in Health Informatics at the Yale School of Public Health.
Postdoctoral trainees who already have a doctoral degree in informatics or a closely related field, may not
require additional training in informatics or data science. The focus of our postdoctoral training involves defining
one or two research projects which can be carried out independently (under faculty supervision) and that will
result in publications and grant applications. The overall goal of our program is to provide all trainees with the
necessary background and experience to pursue productive academic and research careers in Biomedical
Informatics and Data Science. Each year the number and quality of applicants to our programs have grown and
we actively work to increase diversity in Pre and Postdoc trainees and core faculty with growing success. We are
requesting support for 9 predoctoral trainees and 8 postdoctoral trainees (including 2 with HIV focus). We have a
core group of faculty who are well-funded, highly skilled and experienced as mentors and educators. The
Biomedical Informatics and Data Science activities at Yale provide many opportunities for trainees to work on
interdisciplinary projects that use large biomedical data sets and tackle key research questions.

Public health relevance
PROJECT NARRATIVE The goal of Yale's Biomedical Informatics and Data Science training program is to provide pre-doctoral and post-doctoral trainees with coursework and research experiences that will allow them to pursue productive research careers in Biomedical Informatics and Data Science. The depth and strength of our curriculum and research experiences emphasize the development of new knowledge to advance the scientific disciplines of biomedical informatics and data science. Finally, our trainees have demonstrated their abilities to carry out independent research at a high level compatible with publication of results and competition for research grants and contracts. 1